Cancer Cell Intrinsic Interferon-I pathway Activation by Fractionated Radiation

Recent evidence indicates that the presence of conventional dendritic cells type 1 (cDC1) in the tumor
microenvironment (TME) is required for response to immune checkpoint blockade (ICB) therapy. In addition to cross-
presenting cancer cell-derived antigens to CD8+ and CD4+ T cells, cDC1 promote tumor infiltration by effector T cells,
and support their survival and function. Thus, interventions that improve cDC1 recruitment to the TME could enhance
patient responses to ICB. Focal radiation therapy (RT) increases responses to ICB therapy, at least in part by inducing
type I interferon (IFN-I) and driving cDC1 into the irradiated tumor. We have previously shown that cDC1 are essential
for immune-mediated regression of irradiated and synchronous non-irradiated tumors (abscopal effect) in mice treated
with RT and ICB. Abscopal responses have also been achieved in metastatic cancer patients treated with RT and ICB, but
less reliably than expected, and the determinants of such responses remain unclear. We hypothesize that a previously
unexplored barrier to abscopal responses is the limited infiltration of poorly immunogenic tumors by cDC1, which
precludes effector T cells generated at the irradiated tumor site from rejecting non-irradiated tumors. Moreover, we
hypothesize that activation of a strong IFN-I response in the irradiated tumor is essential for achieving systemic
activation of natural killer (NK) cells, which can home to non-irradiated tumors and foster the recruitment of cDC1. This
hypothesis is supported by a strong scientific premise which is based on the recent literature and on our extensive
published and unpublished data, including the fact that increased serum IFNb post-RT was the top predictor for abscopal
responses in metastatic lung cancer patients treated with RT+anti-CTLA4 (Nat Med 2018). To test this hypothesis three
independent but related aims that address different mechanistic questions are planned. Aim 1 will investigate the role
of RNA:DNA hybrids, which accumulate in the cytosol of irradiated cancer cells and in the cargo of small extracellular
vesicles (sEV) they produce, in activating the IFN-I pathway via cGAS/STING in cancer cells and locoregional DCs. The role
of RT-induced IFNb in systemic NK cell activation will be confirmed by using IFNAR1-deficient NK cells. Aim 2 will
determine the contribution of sEV to RT-induced IFN-I activation in vivo by using Rab27a-deficient cancer cells. Aim 3 will
directly address the role of NK cells in driving cDC1 infiltration in abscopal tumors and abscopal responses to RT+ICB. In
addition, NK cell functional subsets present in the blood of lung cancer patients with abscopal response to RT+anti-
CTLA4 will be investigated by single cell analysis. Results of proposed studies will identify a novel mechanism whereby
local IFN-I induction by RT activates a systemic cross-talk between NK cells and cDC1, required for T-cell mediated
rejection of abscopal tumors.

Public health relevance
NARRATIVE Radiation therapy applied to one tumor has the ability to induce anti-tumor T cell responses that, in combination with immune checkpoint blockade therapy, cause systemic tumor regression. The goal of this proposal is to understand the mechanisms that enable the immune response elicited at the irradiated tumor site to be effective against non-irradiated metastases. This information will fill knowledge gaps about the role of radiotherapy in enhancing responses to immunotherapy, and possibly identify candidate biomarkers and actionable targets to improve cancer patients selection and treatment.